Targeting Gram-Negative Bacteria for Antibacterial Strategies

Project Summary/Abstract
The cell wall is a structural edifice critical for survival of bacteria. Its biosynthetic machinery and the cell wall
itself are targets of antibiotics. Cell wall is a crosslinked polymer that encases the entire bacterium, whose
structure has been estimated to be larger than the chromosome. The complex biosynthetic and recycling
processes of cell wall and its regulation during homeostasis are largely unknown. The Mobashery laboratory
studies these processes in the Gram-negative bacterium Pseudomonas aeruginosa, with emphasis on cell-wall
recycling. Two directions are proposed. The first is the study of the cytoplasmic pathway for recycling of
muropeptides, which are fragments of the cell wall that have been internalized to the cytoplasm. A sequence of
six enzymatic reactions constitutes this pathway, which brings the metabolites to a point of merger with the de
novo pathway for the biosynthesis of cell-wall precursors. We proposed to investigate the mechanistic details
of these enzymes individually. Meanwhile, all six genes have been cloned and the respective recombinant
proteins have been purified to homogeneity. We have reconstituted the pathway in vitro and we have been
able to observe the full metabolic flux for it. The reconstituted pathway has been miniaturized as a
fluorescence assay for high throughput screening of compounds as inhibitors of these enzymes. An argument
is presented that an inhibitor of the de novo biosynthesis (fosfomycin) should synergize well with an inhibitor of
any step in the recycling pathway, whereby the action of the two inhibitors should shut down biosynthesis of
the peptidoglycan entirely, which will be fatal for the Gram-negative bacteria. In the second direction, the
mechanistic nexus between cell-wall recycling and manifestation of resistance to b-lactam antibiotics has been
established. Historically, b-lactam antibiotics have been antibiotics of choice for treatment of infections by
Gram-negative bacteria, including P. aeruginosa. In an attempt to disrupt this link, we have devised a
fluorescent reporter strain of P. aeruginosa that fluoresces when cell-wall recycling takes place. The screening
of a focused natural-product library (390 compounds) against the reporter strain for shutting down cell-wall
recycling potentiates the activity of the b-lactam antibiotics, which otherwise will be ineffective in treating the
resistant bacterium. Several compounds were identified with activity in this screening. We plan to screen two
additional compounds libraries, at which time the positive hits will be assessed for selection of one or more for
synthesis and evaluation of analogs with enhanced activity against a broader collection of Gram-negative
bacteria.

Public health relevance
Project Narrative Antibiotic-resistant bacteria present clinical challenges in treatment of infections. We describe in this grant application two strategies in discovery of agents that can overcome resistance by Gram-negative bacteria. The outlined science is critical in opening opportunities for development of future generations of antibiotics.